COREProgram in Macromolecular Structure, Motion, Control

The CORE laboratory provides facilities to all members of the Yale Center for Structural Biology for the[unreadable] investigation of macromolecular systems by X-ray crystallography and X-ray small-angle scattering, including[unreadable] both instruments for data collection, and computers for data reduction and analysis. Among the computers[unreadable] available are several molecular graphics systems, which are vital to the activities of all users. The staff of[unreadable] the CORE laboratory maintains and upgrades CSB instrumentation, and assists users with data collection[unreadable] and analysis. The CORE staff also maintains the CSB website, which is heavily used by structural biologist[unreadable] both inside and outside Yale. This invaluable resource provides its users with access to all the programs[unreadable] and data bases that are generally useful to structural biologists. The programs on the web site are upgraded[unreadable] as new releases appear, and documentation is provided for many of them to further assist users.